A rapid point-of-care test for therapeutic drug monitoring of tacrolimus

ABSTRACT
This proposal seeks to develop and characterize a point-of-care testing platform to enable rapid, bedside, or at-
home measurement of tacrolimus (TAC), a critical immunosuppressive drug used in organ transplantation. As
TAC accounts for approximately 90% of renal transplant regimens and requires lifelong therapeutic drug
monitoring (TDM) due to its narrow therapeutic index, the current reliance on centralized laboratory testing and
venous blood draws presents significant challenges. These challenges include delays in dosage adjustments,
increased healthcare costs, and substantial logistical burdens for patients and providers. To address these
issues, BioStealth will adapt the D4 immunoassay platform, originally developed at Duke University, for the
detection of small molecules like TAC. Our project is motivated by the pressing need for a more accessible and
timely method for TAC monitoring that could improve both short- and long-term outcomes in transplant patients.
By enabling bedside or patient-led monitoring, we aim to replace the current clinical paradigm, which often results
in delayed dose titrations, increasing the risk of either organ rejection due to under-suppression or drug-related
toxicity due to over-suppression. Furthermore, our technology holds the potential to facilitate the implementation
of area-under-the-curve (AUC)-based dosing, a strategy that has been shown to reduce toxicity but is rarely
used in clinical practice due to the complexity and demands of current TDM approaches. The career development
plan is designed to equip the PD/PI with the entrepreneurial and operational skills necessary to transition into a
leadership role in the biotech industry. With a strong background in biomedical engineering and hands-on
experience with the D4 immunoassay platform, the PD/PI seeks to fill gaps in startup activities, project
management, and commercialization. This will be achieved through structured programs like C3i or I-Corps,
regular mentoring from experienced professionals, and active participation in networking and learning
opportunities. The mentor, Dr. Ashutosh Chilkoti, will provide ongoing guidance in both scientific and
entrepreneurial aspects, ensuring the PD/PI is well-prepared to lead BioStealth toward successful
commercialization.

Public health relevance
PROJECT NARRARTIVE The goal of the proposed work is to develop a point-of-care test capable of rapidly measuring the immunosuppressive drug tacrolimus in organ transplant patients. If successful, this technology will significantly impact transplant patient management by reducing the need for frequent clinic visits, as current methods require venous blood draws tested in centralized labs. Moreover, this versatile technology can be easily adapted to measure other clinically relevant biomarkers, enhancing its broader scientific impact.